Assessing Anxiety in Adolescents with Autism Spectrum Disorder: The Role of Autonomic Activity as a Biomarker

Children with autism and anxiety exhibit significantly more self-injurious behavior, more depressive symptoms, poorer relationships with teachers, peers, and family members, and higher levels of aggressive behavior relative to children with autism without anxiety symptoms. Yet, identifying anxiety in autism populations can be difficult, emphasizing the need for objective measures of anxiety. Autism research has historically focused on primarily White samples. Thus, investigating developmental risk and protective factors that are associated with anxiety symptoms within a more representative autistic population is critical to prevent or reduce negative mental health outcomes. Therefore, the current study aims to collect a large sample of autistic and nonautistic adolescents to evaluate whether the presence of atypical autonomic activity is a biomarker of anxiety in autistic youth. This proposal has three aims: 1) to investigate the association between baseline autonomic activity and anxiety levels in adolescents with and without autism; 2) to examine the role of ecological context and its relation with baseline autonomic activity and anxiety in adolescents with and without autism; and 3) to utilize real world experience sampling and noninvasive heart rate monitors to capture real-time data on autonomic activity, anxiety levels, and ecological context in the natural settings of adolescents with and without autism. Such knowledge will allow for identification of anxiety in autistic youth that would otherwise be unable to report on anxiety and inform the development of interventions that promote emotional well-being.
In the transfer of my funded NIMH-K08 career development plan, I will continue to undertake training with my primary mentor, Dr. Stephen Thomas, at the University of Maryland to explore aspects of the ecological context and how those experiences relate to autonomic activity and anxiety. Additionally, I will acquire core knowledge in psychophysiology as related to the parasympathetic nervous system, develop expertise in the assessment of anxiety, receive advanced training in quantitative methodology for multilevel modeling of intensive longitudinal data, and training in ecological momentary assessment best practices. Successful completion of these aims would lay the groundwork for validating the use of autonomic activity as an objective transdiagnostic biomarker of anxiety in autism and contribute to the development of targeted interventions that promote emotional well-being, empower youth with autism, and improve their overall quality of life. Completion of the training goals will prepare me as an independent researcher in the fields of autism, developmental psychopathology, and clinical science.

Public health relevance
Investigating developmental risk and protective factors that are associated with anxiety symptoms in the autistic population is critical to prevent or reduce negative mental health outcomes. The current study aims to collect a large sample of autistic and nonautistic adolescents to evaluate whether the presence of atypical autonomic activity is a biomarker of anxiety in autistic youth. Such knowledge will allow for identification of anxiety in autistic youth that would otherwise be unable to report on anxiety and inform the development of interventions.